Novel Extracorporeal Therapy for the Reversal of Septic Shock and Restoring Hemodynamic Stability

PROJECT SUMMARY
The funds from this administrative supplement will be utilized for Technical and Business
Assistance (TABA). Specifically, we intend to use the funds to cover intellectual property
strategy consultation fees to provide us with a sound patent strategy for our novel polymer
sorbent LPSorb.
Sepsis is an extreme reaction to pathogen infection and is one of the deadliest conditions in the
world. The field of sepsis care currently lacks an effective treatment to counteract both the
bacterial-derived endotoxins found in certain types of sepsis and the massive cytokine-mediated
immune response to the infection that can lead to organ failure and death.
LPSorb has demonstrated the potential to be an extremely effective extracorporeal endotoxin
adsorber. When coupled with our cytokine adsorber CytoSorb, which is currently on the market,
LPSorb should provide a novel and effective therapy for deadly Gram-negative sepsis.
The innovative formulation developed by our polymer chemistry team will require intellectual
property protection to allow for continued innovation and to provide maximum revenue, enabling
the establishment of a viable new product line for the company.
To achieve this, we propose to use these supplemental funds to engage our longtime IP
counsel BakerHostetler to seek intellectual property counsel to develop a suitable patent
strategy which will ultimately enable us to efficiently pursue both material and application
patents for this innovative product.

Public health relevance
PROJECT NARRATIVE Sepsis is an extreme reaction to pathogen infection and is one of the deadliest conditions in the world. The field of sepsis care currently lacks an effective treatment to counteract both the bacterial-derived endotoxins found in certain types of sepsis and the massive cytokine-mediated immune response to the infection that can lead to organ failure and death. Our novel polymer LPSorb is capable of efficient endotoxin removal directly from septic plasma. This supplemental funding will allow us to seek legal advice from the BakerHostetler law firm to help provide intellectual property protection for our polymer for use in this application.